Decreasing Delirium through music (DDM) in critically ill older adults.

Project Summary/Abstract:
Older adults admitted to the intensive care unit (ICU) for treatment of critical illness/injury with invasive
mechanical ventilatory support are at high-risk for development of a number of adverse acquired sequelae.
One of the direst is occurrence of delirium, a type of acute brain dysfunction syndrome. Delirium increases
risk for prolonged ICU stay, increased duration of hospitalization as well as significant morbidity and even
increased mortality. Further, duration and severity of delirium elevates the risk of cognitive decline and
development of Alzheimer's disease and related dementias (ADRD). While there are no medications that
effectively treat delirium, nonpharmacological interventions that can prevent or reduce the occurrence,
duration and severity of delirium hold great promise. However, it is not known if these interventions can
reduce cognitive decline and the downstream risk of ADRD in older adults. This administrative supplement
will begin to address this significant scientific gap by leveraging our on-going Decreasing Delirium through
Music in Older Adult ICU Patients (DDM) clinical trial (R01AG067631) by extending the post-ICU
neuropsychological assessments of brain health and investigate the shared pathophysiological pathways
between delirium and cognitive decline/ADRD. DDM ICU treatment is hypothesized to result in lower levels
of acute neuroinflammation, microglial and astrocyte activation, and neuronal injury which will reduce the
duration and severity of ICU delirium and lead to improved post-ICU cognitive outcomes, slower
progression of ADRD pathology through lower risk of cognitive impairment and ADRD. We will test this
hypothesis with two specific aims: A1) Test the efficacy of the DDM treatment in slowing the rate of post-
ICU cognitive decline in mechanically ventilated patients as compared to attention
control. Neuropsychological assessments will be completed at 6- and 12-months after hospital discharge.
A2) Determine whether DDM treatment is associated with slower progression of ADRD pathology in older
adult ICU survivors. Blood biomarkers of neurodegeneration (neurofilament light), phosphorylated tau-181
glial fibrillary acidic protein, and S100B; AD pathology (Aβ42/Aβ40), vascular pathology (C-reactive protein)
and inflammation (interleukins 1, 6, and 8) will be collected in ICU, 6- and 12 months after hospital
discharge. Analysis will consist of descriptive statistics and mixed effects models. Results will be used to
inform a future R01 proposal to test the efficacy of DDM ICU music interventions to reduce the risk of
cognitive decline and ADRD in older adult ICU survivors, and to characterize the neuroprotective
mechanisms of music in patients at high risk for ADRD.

Public health relevance
Project Narrative: Older adults admitted to the intensive care unit (ICU) are at substantial risk for delirium, a syndrome of acute brain dysfunction with significant morbidity and mortality that also is linked to downstream cognitive impairment after hospital discharge that can lead to development of Alzheimer's disease and related dementias (ADRD). Slow-tempo music listening early during the ICU stay is hypothesized to mitigate delirium and protect brain health. We propose to test this hypothesis by investigating the neuroprotective mechanisms of music interventions by assessing neuropsychological outcomes at 6- and 12-months after hospital discharge, as well as collect blood biomarkers of neurodegeneration, inflammation and vascular pathology that share biological pathways between delirium and subsequent ADRD development.